FUNCTIONAL MAGNETIC RESONANCE IMAGING AND DIFFUSION TENSOR IMAGING IN CHILDREN

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to characterize structural and functional neuroimaging abnormalities in Children with a recent history of mild traumatic brain injury (mTBI).